Role of Scn1b in Susceptibility to Neuropathic Pain

Project Summary
This goal of this R21 project is to jumpstart mechanistic research on the role in neuropathic pain of SCN1B, an
understudied druggable protein. Neuropathic pain is a debilitating, chronic condition that represents a major
medical burden in the US. Current standards of care are ineffective both for preventing pain chronicity after nerve
injury, and for providing long-term relief for neuropathic pain. Individuals show different susceptibilities to
neuropathic pain and experience diverse sensory symptoms; however, little is known about the genetic factors
that predispose individuals to chronic sensory dysfunction. Thus, there is a need to understand the mechanisms
that that underlie neuropathic pain, because such molecules are potential therapeutic targets and biomarkers of
susceptibility. In a screen for natural genetic variation among genetically distinct mouse strains, we identified
Scn1b as a top candidate susceptibility gene for tactile hypersensitivity in a mouse model of paclitaxel-induced
neuropathic pain (PIPN). The Scn1b gene encodes the auxiliary β1 subunit of voltage-gated Na+ channels,
which are key regulators of neuronal excitability because they mediate the upstroke of the action potential.
Scn1b expression is highly enriched in myelinated mechanosensory neurons that provide sensory drive for tactile
allodynia in persistent pain. Based on these results, this project’s central hypothesis is that SCN1B plays a key
role in the development of tactile allodynia in mouse models of neuropathic pain by governing the excitability of
mechanosensory neurons. This hypothesis will be tested with a combination of sensory neuron-specific Scn1b
knockout mice, electrophysiological studies and a battery of behavioral tests for somatosensory and motor
behaviors. Aims are to: 1) determine whether Scn1b is a susceptibility factor for neuropathic pain in a mouse
CIPN model; and 2) determine whether Scn1b is required for the development of neuropathic pain in a spared-
nerve injury model. If successful, this research will generate essential pilot data that will rapidly catalyze future
research to elucidate mechanisms through which Scn1b promote neuropathic pain, develop SCN1B as a new
therapeutic target, and validate Scn1b as a biomarker for neuropathic-pain susceptibility.

Public health relevance
Project Narrative Millions of people worldwide suffer from neuropathic pain. This proposal aims to validate a new peripheral target for regulating neuropathic pain signaling. Understanding the neural mechanisms that promote persistent pain may lead to the development of much needed, novel drugs and therapies.